Cell-Cell Signaling Driving HPV-Induced Respiratory Disease and Vaccine Response

ABSTRACT
This patient-centric collaborative translational research project will define cellular and viral biomarkers and
mechanisms dictating recurrent respiratory papillomatosis (RRP) patient response to the HPV therapeutic
vaccine PRGN-2012. RRP is a debilitating neoplastic disease caused by chronic infection with HPV types 6 and
11 that has no approved medical therapies. A recently published phase 1 clinical trial led by Dr. Clint Allen at the
NIH Clinical Center demonstrates that treatment with the gorilla adenovirus-based HPV vaccine PRGN-2012
results in a 50% response rate in patients with severe, aggressive RRP. Our long-term goal is to maximize
vaccine treatment effectiveness and confer response in patients who are currently non-responsive. Correlative
data limited to pre-treatment papillomas linked the state of the tumor microenvironment to vaccine response.
Specifically, response was associated with a) low HPV gene expression, b) low stress keratin 17 (K17)
expression, c) high expression of the CD8 T cell chemokines CXCL9-11, and d) prominent CD8 T cell infiltration.
Conversely, non-response was associated with a) high HPV gene expression, b) high K17 expression, c) low
CXCL9-11 and high neutrophil chemokine CXCL8 expression, and d) prominent neutrophil infiltration with
diminished T cell activation. The current proposal greatly expands this correlative clinical data by defining
response-related reprogramming in specific epithelial and immune cell subpopulations, extends analysis to
paired pre- and post-treatment clinical samples to define phenotypic response outcomes as goals for effective
therapy, and tests the hypothesis that high HPV load and gene expression in RRP papilloma epithelial cells
attenuates CXCL9-11/CD8 T cell responder phenotypes by inducing K17. We will comprehensively define
epithelial and immune cell subpopulations and intercellular signaling using single cell and spatial transcriptomics
on pre-treatment and post-treatment papillomas from responders and non-responders collected as a component
of the planned prospective phase 3 clinical trial that will power the trial to validate clinical response rates (Aim
1). Complementary mechanistic studies will elucidate the functional role of high vs low HPV gene expression in
dictating epithelial phenotypes, cytokine signaling, and immune cell activation and infiltration using isogenic
patient-derived organotypic epithelial rafts with low vs high HPV load (Aim 2). Epithelial and immune cell
subpopulations and intercellular signaling will be profiled by single cell and spatial transcriptomics for integration
with responder and non-responder clinical tissue data. Candidate molecules mediating responder vs non-
responder phenotypes, including K17, will be mechanistically tested using pharmacologic, and loss and gain-of-
function approaches. These studies unite the epithelial/HPV biology, immunology, pathology, and clinical
expertise of an established partnership between Drs. Wells and Wikenheiser-Brokamp at Cincinnati Children’s
Hospital and intramural NIH/NCI collaborator Dr. Allen to advance fundamental understanding of RRP
pathobiology for development of new treatments that overcome mechanisms of resistance to effective therapies.

Public health relevance
NARRATIVE Recurrent respiratory papillomatosis (RRP) is caused by chronic human papillomaviruses (HPV) 6 and 11 infection leading to neoplastic airway tumors whose repeated growth requires patients to undergo frequent surgeries and can ultimately result in difficulty speaking and swallowing, cancer development, and death. A new HPV vaccine, PRGN-2012, was recently shown to induce complete responses in 50% of RRP patients with robust clinical responses correlated with low HPV gene expression, CXCL9-11 chemokine signaling, and robust CD8 positive T cell infiltration into the papillomas. We will use cutting edge omics approaches on patient specimens together with engineered patient derived 3D RRP models to define cellular and viral mechanisms driving vaccine response to identify response biomarkers and molecular targets to optimize PRGN-2012 therapeutic efficacy.